Expanding access and enrollment to precision medicine trials in Acute Myeloid Leukemia

Abstract
Outcomes for Acute Myeloid Leukemia (AML) remain poor, with 30% 5-year overall survival, and most AML
patients are not treated on clinical trials. The objective of this R50 Clinician Scientist Award application is to
address two critical barriers to enrolling patients to precision medicine trials in AML: 1) the limited availability of
rapid molecular testing; and 2) community and patient education regarding the importance of clinical trials in
AML. The NCI MyeloMATCH studies feature rapid centralized molecular testing and clinical trial assignment.
Not all patients are candidates for these studies and not all trials offer this option, and there remains a need for
rapid in-house molecular testing for all patients with AML. Furthermore, outcomes for African American and
Hispanic patients with AML are worse than white patients. Differences in disease biology contribute to the
outcomes disparity for African American patients, spotlighting the need for prospective study in clinical trials.
Minority patients are profoundly under-represented in trials of new drugs approved in AML, with no trial
enrolling more than 10% African American and Hispanic participants combined. There is an urgent need to
expand access to precision medicine trials in AML to all patients, and especially to under-represented minority
patients, as we develop innovative, targeted treatments. The FDA has approved 11 new drugs in AML since
2017. However, it remains unclear how to use these drugs in combination or sequence, and there is little
randomized data for these newer agents against each other. The NCI cooperative groups are the only US
clinical research mechanism with the ability to answer these critical research questions and potentially
transform AML treatment. Single-arm, single-institution studies are hypothesis-generating, but MyeloMATCH
is critical due to its unique ability to bring investigators together to design trials and put strategies to the test in
larger patient populations at more sites. If we do not aggressively enroll to these studies, we will miss the
window of opportunity to better understand how these newer agents work in specific AML subsets, how they
perform compared to each other, and how resistance develops. I will lead a focused effort to address barriers
to access and enrollment for precision medicine trials in AML which includes: leveraging the NCI MyeloMATCH
program; developing dynamic, in-house rapid molecular testing for AML patients; and expanding University of
Kansas Cancer Center (KUCC) clinical trials outreach efforts to underserved patients across our catchment
area. Salary support and protected time through the R50 mechanism will allow me to expand leukemia and
clinical research efforts across the catchment area, developing strategies which can serve as a model for other
disease teams at KUCC. My roles as Director of the Acute Leukemia Program, Medical Director of the KUCC
Clinical Trials Office (CTO), SWOG representative to the NCI MyeloMATCH Younger Adult AML Working Group
and on the KUCC Health Equity Committee give me the necessary skills to successfully lead these efforts.

Public health relevance
Outcomes for Acute Myeloid Leukemia (AML) remain poor, with 30% 5-year overall survival, and most AML patients are not treated on clinical trials. The objective of this R50 Clinician Scientist Award application is to address two critical barriers to enrolling patients to precision medicine trials in AML: 1) the limited availability of rapid molecular testing; and 2) community and patient education regarding the importance of clinical trials in AML. The upcoming NCI MyeloMATCH studies will feature rapid centralized molecular testing and clinical trial assignment. Not all patients are candidates for these studies and not all trials offer this option, and there remains a need for rapid in-house molecular testing for all patients with AML. Furthermore, outcomes for African American and Hispanic patients with AML are worse than white patients. Differences in disease biology contribute to the outcomes disparity for African American patients, spotlighting the need for prospective study in clinical trials. There is an urgent need to expand access to precision medicine trials in AML to all patients, and especially to African American patients, as we develop innovative, targeted treatments. The FDA has approved more than a dozen new drugs in AML since 2017. However, it remains unclear how to use these drugs in combination or sequence, and there is little randomized data for these newer agents against each other. The NCI cooperative groups are the only US clinical research mechanism with the ability to answer these critical research questions and potentially transform AML treatment. Single-arm, single-institution studies are hypothesis-generating, but MyeloMATCH is critical due to its unique ability to bring investigators together to design trials and put strategies to the test in larger patient populations at more sites. If we do not aggressively enroll to these studies, we will miss the window of opportunity to better understand how these newer agents work in specific AML subsets, how they perform compared to each other, and how resistance develops. I will lead a focused effort to address barriers to access and enrollment for precision medicine trials in AML which includes: leveraging the NCI MyeloMATCH program; developing dynamic, in-house rapid molecular testing for AML patients; and expanding University of Kansas Cancer Center (KUCC) clinical trials outreach efforts to patients across our catchment area. My roles as Director of the Acute Leukemia Program, Medical Director of the KUCC Clinical Trials Office (CTO), SWOG representative to the NCI MyeloMATCH Younger Adult AML Working Group and on the KUCC Health Equity Committee have given me the necessary skills to successfully lead these efforts.